The impact of health disparities and alcohol use on late diagnosis of HIV in Florida: Understanding missed opportunities using a statewide dataset

Project Summary/Abstract
Late diagnosis of HIV is a significant public health problem due to increased risk for morbidity and mortality and
the potential for HIV transmission. This Kirschstein NRSA Predoctoral Fellowship (PA-21-051) proposal aims
to conduct an interdisciplinary multiphase explanatory sequential mixed-methods study to better understand
the social-ecological factors associated with late HIV diagnosis, examine longitudinal HIV health outcomes
(e.g., CD4 count and viremia), identify facilitators/barriers to HIV testing and healthcare engagement, and
understand the impact of alcohol. This proposal responds to the National HIV/AIDS Strategy to identify missed
opportunities for diagnosis, the Ending the HIV Epidemic Initiative to reduce late diagnosis, and the National
Institute on Alcohol Abuse and Alcoholism (NIAAA)’s Strategic Plan to understand how alcohol affects HIV
disease progression. Recent literature investigating factors associated with late is limited in United States
populations. Moreover, there is not a consensus on the clinical definition of late diagnosis; common definitions
are “traditional” CD4 count<200 cells/mm3 and “expanded” CD4 from 200 cells/mm3 up to 350 cells/mm3,
though no studies to date have compared these definitions by significant covariates or longitudinal outcomes.
The effect of alcohol is also understudied despite known associations with worse health and care engagement.
To achieve the goals of this study, we will link two statewide datasets of people with HIV (PWH) in Florida:
Medical Monitoring Project (MMP) and Enhanced HIV/AIDS Reporting System (eHARS) data collected
between 2015-and 2019 (N=2,000). First, we will determine the incidence and describe demographic,
behavioral, and psychosocial disparities between those with and without multiple definitions (traditional vs
expanded) of late HIV diagnosis. Second, we will create generalized linear mixed effect models to compare
longitudinal outcomes by late diagnosis and assess potential effect modification of heavy alcohol; we will use a
subset of this data including only those diagnosed between 2015-and 2019 (N=200). Finally, we will explore
reasons for late diagnosis, identify missed opportunities for testing, and determine new intervention points
through qualitative interviews with 20-25 PWH with late HIV diagnosis in the Southern HIV and Alcohol
Research Consortium (SHARC) contact registry (N=750). Findings will inform intervention and policy targets
to reduce late diagnosis by identifying health disparities and missed opportunities for testing and healthcare
engagement. A benefit of this award is training to establish the foundation of a successful career in
epidemiologic research and intervention science such as 1) learning strengths, limitations, and implications of
using multidimensional public health data to measure substance use and health outcomes; (2) understand the
rationale for using different statistical methods to answer longitudinal research questions with public health
data; and (3) leading collection and analysis of qualitative data as part of a mixed-methods study, in addition to
developing skills such as manuscript production and giving presentations.

Public health relevance
Project Narrative Despite efforts to implement universal HIV testing in the United States, late HIV diagnosis—diagnosis at an advanced stage of infection—remains highly prevalent, contributes to increased morbidity and mortality among people with HIV as well as transmission of infection, and is a priority to address to end the HIV epidemic. The proposed research will provide a fuller understanding of 1) the current demographic, behavioral, and psychosocial health disparities associated with late diagnosis using a large public health surveillance dataset; 2) the longitudinal HIV clinical outcomes (e.g. viremia and CD4 count) post-late diagnosis; 3) the clinical significance of different definitions of late diagnosis on longitudinal outcomes and factors associated with different definitions; 4) reasons for late diagnosis and lack of engagement in healthcare not captured in routine surveillance and survey data, and 5) the influence of alcohol specifically on the late diagnosis and HIV outcomes. The results of this research can inform impactful interventions and policies to reduce late diagnosis by identifying health disparities and multidimensional barriers to and missed opportunities for HIV testing and engagement in healthcare.